Glycosphingolipids from the Soil Microbiome, Understanding Structure and Biosynthesis

Project Summary
The production of the glycosphingolipid α-galactosylceramide (α-Gal) by a member of the human gut microbiome
was an intriguing discovery because these lipids are known to be immune stimulating antigens, and their
production by the gut microbiome suggests a role in host-microbiome signaling. α-Gal is the canonical agonist
for the immune system's CD1d receptor, but synthetic work has shown that when the α-linked galactose is
replaced with novel sugars or sugar bioisosteres, the activity of the glycosphingolipid in immune signaling can
change dramatically. These results suggest that soil dwelling members of the order Sphingomonadales bacteria,
which produce these glycosphingolipids, are a source of novel bioactive metabolites. In this project, we have
designed a soil enrichment screen using PCR amplification of the serine palmitoyltransferase (SPT) gene, the
first gene involved in sphingolipid synthesis, to identify sphingolipid producers. Follow-on lipidomic screening of
SPT+ organisms on our laboratory's QTOF LC-MS system will identify novel glycosphingolipids. By utilizing
MS/MS fragment spectra analysis, we will be able to identify sugar headgroups in our glycosphingolipids from
neutral losses of the sugar monomers or the sugar fragment ions. Using GNPS-based molecular networking we
will also be able to rapidly dereplicate known glycosphingolipid molecules, speeding up the process of identifying
known chemistry to allow us to focus our efforts on novel sugar headgroups. With the novel organisms we isolate,
we will conduct Whole Genome Sequencing (WGS) with Oxford Nanopore Technology's nanopore platform to
create a genomic data set that can be searched for the SPT gene. Inspired by the “glycogenomic” approach of
mapping sugar chemistry in secondary natural products to biosynthetic gene clusters, we will also interrogate
our genomes compared against the glycosphingolipids identified by LC-MS/MS analysis to identify candidate
genes in the biosynthetic pathway after the SPT gene. Though this poses some unique challenges as
sphingolipids are primary metabolites and their biosynthesis is not organized in tight biosynthetic gene clusters
as is common in secondary natural products, the use of gene knockouts or heterologous expression can help
confirm the role of these genes in the production of complex glycosphingolipids. We will also be able to utilize
the known promiscuity of bacterial SPT genes to feed in unnatural lipid molecules, using LC-MS/MS monitoring
to detect the novel glycosphingolipids produced by the incorporation of these feedstocks, demonstrating what
strains might be able to be manipulated into producing compounds with desirable changes to the lipid tail of the
glycosphingolipids. Glycosphingolipids isolated from the scale-up of the cultures will be further characterized by
NMR to confirm our structure assignment by MS/MS fragmentation analysis. Finally, we will evaluate the newly
identified glycosphingolipids for their cytokine elicitation from macrophages as a first step toward showing the
clinical relevance of our glycosphingolipid library.